ELUCIDATION OF GLYCAN EXPRESSION ON THE ST6GALNAC V TRANSFECTED MDCK CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. In this study, Dr. Shiloach's group transfected the MDCK cells with the human sia7te gene (ST6GalNAc V) for use as an alternative to embryonated eggs for influenza virus propagation and hemagglutinin (HA) production intended for vaccine manufacturing. We found that the hemagglutinin titer from the siat7e expressing cells was approximately 20 times higher than from the parental MDCK cells and the cell-derived viruses retained similar antigenic properties as those obtained from egg-derived viruses. To understand the mechanism of our findings, we characterized glycan expression on MDCK cells.